Inflammatory Signaling in Kidney Stromal Cells Driving Interstitial Fibrosis

PROJECT SUMMARY/ABSTRACT
A growing body of evidence indicates that molecular signaling mechanisms mediated by the myddosome
complex in kidney stromal cells, drive fibrosis triggered by interleukin 1b (IL1b) and Toll-like receptor (TLR)
ligands. Work from our laboratory and by others has shown that signaling mechanisms associated with IRAK4,
a key component of the stromal cell myddosome, contributes to the development of renal fibrosis after acute
kidney injury. IRAK4, therefore, emerges as a suitable target for much needed therapies targeting renal
fibrosis. In order to effectively target IRAK4, however a deeper understanding of its mechanisms is needed.
IRAK4 has been shown to possess two distinct functions, one as a serine/threonine kinase and the other as a
structural scaffold necessary for myddosome formation. Importantly, the role of IRAK4 as a myddosome
scaffold is necessary for its kinase activity, but the latter is not necessary for myddosome-mediated signaling.
We have reported that pharmacologic inhibition of IRAK4 kinase activity with a selective small molecule
significantly reduces pro-fibrotic stromal cell activity, including proliferation and differentiation into
myofibroblasts, both ex vivo in response to IL1β stimulation, and in vivo after ischemic kidney injury. Our data
further indicated that those profibrotic mechanisms depend on stabilization and activation of the transcriptional
regulator MYC via a mechanism involving IL1R-driven autophagy. On the contrary, inhibition of IRAK4 kinase
activity did not result in abrogation of synthesis and secretion of NF-κB-regulated inflammatory cytokines
IL1β and IL6 in kidney stromal cells. Those results are in keeping with previous reports indicating that NF-kB
activation by IRAK4 is myddosome-mediated and only partially dependent on IRAK4 kinase activity. The
objective of this project is to dissect the molecular mechanisms through which IRAK4 mediates kidney fibrosis,
by assessing the distinct contribution of kinase-dependent versus myddosome-dependent IRAK4 signaling
mechanisms. The long-term goal of these studies is to set the pre-clinical basis for novel therapeutics that can
ameliorate both renal fibrosis and local inflammation through blockage of stromal cell pro-fibrotic and pro-
inflammatory activities. The central hypothesis is that following acute kidney injury IRAK4 kinase activity in
stromal cells is necessary for pro-fibrotic mechanisms, while kinase-independent IRAK4-mediated myddosome
assembly is necessary for inflammatory cytokine production by those cells during the process of kidney
scarring. Our rationale for the research strategy proposed is based on a combination of genetic ablation
strategies to study IRAK4 kinase domain-independent mechanisms, along with cutting-edge bioengineered
human kidney organoids for the study of the nephron interstitial microenvironment in the absence of confusing
hematopoietic immune signals. In addition, we propose the use of novel therapeutic chemistry shown to be
effective for inducible targeted degradation of IRAK4 in vivo, abrogating myddosome formation. Our three
specific aims will test three major hypotheses: (Aim 1) IRAK4 kinase function is necessary for profibrotic
mechanisms of kidney stromal cells post-AKI; (Aim 2) signaling via IL1R/IRAK4 stabilizes MYC via a mechanism
involving stromal cell autophagy and degradation of SQSTM1/P62; (Aim 3) pharmacologic abrogation of IRAK4
using a synthetic protein degrader molecule will impair stromal cell myddosome formation and ameliorate IRI-
induced kidney fibrosis. Collectively, these studies will provide critical experimental and mechanistic basis for a
rational design of therapies targeting IRAK4 in renal fibrosis.

Public health relevance
Narrative Kidney fibrosis is a pervasive processes contributing to progressive scarring and loss of renal function. Novel emerging data indicate that specific inflammation-associated molecules can drive the activity of the stromal cells responsible for the process of renal fibrosis with precision, by controlling distinct aspects of the scarring process. We propose that understanding the mechanisms by which such molecules regulate fibrosis will lead to the development of effective therapeutic strategies to prevent the sequelae of kidney injury and reduce kidney scarring.